Age remodels kidney-adrenal-heart interorgan communication

Project Summary/Abstract
Cardiorenal syndrome is an age-associated pathology where the dysfunction of the heart or kidney induces
excess extracellular matrix in the other organ. We propose, and our data supports, that age-associated
dysregulation between interorgan signaling promotes cardiorenal syndrome. Comorbidity, heterogeneity and
gender differences may be better managed by understanding how age affects kidney-adrenal-heart
communication and by what mechanisms these tissues induce fibrosis. This project will transplant adrenal and
kidney tissue between young and aged mice to determine how altered interorgan communication drives aging-
associated cardiac dysfunction. We will study the interaction of age-associated water-loss and interorgan
communication to determine how this impacts cardiorenal aging. Because we find that mammalian renal steroid
hormones can induce heart fibrosis in Drosophila by acting through a novel membrane receptor, we will
determine how this receptor signals to induce fibrosis and identify the corresponding receptor in mammalian
tissues. Overall, this proposal aims to understand how aging impacts interorgan communication to produce age-
associated cardiorenal syndrome and fibrosis, using models of Drosophila and mice.

Public health relevance
Project Narrative Signaling and coordination among organ systems provides functional balance in young, healthy adults. Such interorgan communication is disrupted in the process of aging and contributes to complex, multiorgan loss-of- function. This proposal studies how changes in the communication between the kidney, adrenal gland and heart contributes to age-associated renal and cardiac decline.